DIRECTED DISCOVERY AND VALIDATION OF ANTI-SPLICE-JUNCTION SITE Abs

Abstract
This Fast Track proposal's overarching goal is to develop a comprehensive platform for the
identification and validation of recombinant antibodies (Abs) that are specific to protein isoform
splice-junction sites. This initiative addresses key challenges in the protein-level characterization of
splice variants, which is a critical area in understanding and treating diseases related to alternative
splicing of proteins. The project introduces an innovative "Epivolve" phage display technology,
utilizing a “pseudo-haptenylated” amino acid to generate site-directed Abs against these splice
variants. The initial phase of the project, Phase I, will focus on validating the several existing splice-
site specific Abs through methods such as western blotting and flow cytometry, with a vision to
expand applications in future offerings. And the use of Epivolve to generate Abs de novo from phage
display libraries to the same sites as a proof of concept. This strategy is significant as alternative
splicing is known to contribute to the malignant progression of cancer, highlighting the potential
impact of this research in oncology. Phase II of the proposal takes the project further by producing
display libraries in a novel vector system that combines phage- and yeast display technologies. A
key aspect of this phase is the targeted effort to identify potential neoantigens near the amino
terminus of G-protein-coupled receptors, a potentially promising area in cancer research.
Additionally, the proposal outlines a commercialization strategy, reflecting the project's progression
towards practical applications. The final step in this strategy involves scaling up the production of
these site-directed Abs and continuing their validation. This phase is crucial to ensure the
effectiveness and reliability of the Abs for broader use, potentially revolutionizing the approach to
diagnosing and treating diseases related to protein splicing.

Public health relevance
Narrative This proposal aims to develop a platform for identifying and validating specific types of antibodies, with a focus on addressing challenges in a particular area of disease research. The first phase of the project will validate existing antibodies using standard methods and produce new ones on the same sites as proof of concept. The second Phase involves increasing the production of new isoform-specific antibodies and ensuring they are effective and reliable for broader use, which could significantly change the approach to diagnosing and treating diseases related to this specific area of protein research.